MD Anderson Cancer Immune Monitoring and Analysis Center MDA-CIMAC

ABSTRACT
Immunotherapy (IMT) has emerged as a promising treatment strategy across a broad spectrum of human
cancers, with multiple agents, particularly immune check point inhibitors, showing promising results in various
types of cancers. Its full potential has yet to be realized, due in part, to a lack of biomarkers predicting response
to treatment. Multiple immune and genomic biomarkers of response based on analysis of pre-treatment
specimens have been described but most are not very robust with significant overlap between responders and
non-responders. Therefore, there is a critical unmet need to perform comprehensive characterization of
candidate biomarkers in early phase IMT trials using standardized assays and novel methodologies. Recognizing
the need for comprehensive immune monitoring for IMT clinical trials, in 2017 NCI developed the Cancer Immune
Monitoring and Analysis Center (CIMAC) and Cancer Immunologic Data Commons (CIDC) Network, with the
goal of identifying biomarkers of response, resistance, and adverse events to optimize immunotherapy
approaches for patients with cancer. The MD Anderson Cancer Immune Monitoring and Analysis Center
(MDA-CIMAC) is one of four CIMAC sites established five years ago that has been standardizing genomic,
pathology and immunology assays and supporting profiling of tissue and blood specimens from patients treated
in IMT trials. The MDA-CIMAC will be co-led by Drs. Ignacio Wistuba, renowned cancer surgical and molecular
pathologist, Gheath Al-Atrash, well-known medical oncologist with expertise in stem cell transplantation and
immunotherapy, and Cara Haymaker, cancer immunologist with expertise in immune biomarker analysis. They
will be supported by a multidisciplinary team of world-class and highly collaborative experts on cancer and
immunotherapy. The main goals of MDA-CIMAC are to: 1) provide a centralized and harmonized platform for
sample collection, processing and quality assurance, and 2) use analytically-validated and standardized (Tiers
1 and 2) and highly innovative (Tier 3) assays to offer analyses for phenotypic, genomic, and functional
characterization of responses of patients enrolled on IMT clinical trials. In Aim 1, we will utilize Standard
Operating Procedures (SOPs) following the developed CIMAC umbrella protocol to provide services for
processing and distribution of annotated biospecimens from the NCI-sponsored early phase immunotherapy
clinical trials and to link the specimens to relevant clinical, pathological, immune and molecular data within the
CIMAC-CIDC Network. In Aim 2, we will perform routine and innovative pathological, immunological and
molecular analyses using standardized and validated and highly innovative assays to aid the completion of NCI-
sponsored early phase clinical trials and the development of novel predictive IMT biomarkers. In Aim 3, in
conjunction with the CIDC team, we will provide biostatistics and computational services for data collection and
analysis, and will perform, interpret and predict modeling of high dimensional (‘omic”) data. We envision that the
MDA-CIMAC will be indispensable as we make meaningful progress in cancer immunotherapeutic approaches.

Public health relevance
PROJECT NARRATIVE Immunotherapy (IMT) has emerged as a promising treatment strategy across a broad spectrum of human cancers, with multiple agents, particularly immune check point inhibitors, showing promising results in various types of cancers. Its full potential has yet to be realized, partly due to a lack of biomarkers predicting response to treatment. Current immunotherapeutic approaches are mostly unsuccessful due to limited understanding of the tumor microenvironment, limited clinical utility of current immune markers and inconsistent use of assays or technologies that produce meaningful interpretations in studies. The MD Anderson Cancer Immune Monitoring and Analysis Center (MDA-CIMAC) will provide a centralized and harmonized platform for sample collection, processing and quality assurance and use analytically-validated and standardized assays and highly innovative assays and methodologies to offer state-of-the-art analyses for phenotypic, genomic, and functional characterization of responses of patients enrolled on NCI-sponsored early phase immunotherapy clinical trials leading to the identification of biomarkers that will ultimately improve the therapeutic strategies for cancer patients.